Transforming Hypertension Management in Nigeria

PROJECT
ABSTRACT
Elevated
and
based
very
blood pressure (BP) is a leading modifiable risk factor f or global cardiovascular disease morbidity
mortality. In Nigeria, the most populou country in sub-Saharan Africa, the prevalence of hypertension
on a BP threshold >140/90 mmHg in adults (>40 years) has been estimated to be 45%. 1 Despite this
high burden, hypertension awareness (14-30%), treatment (<20%), and control (9%) rates are very low in
s
Nigeria. 2 A 2018 systematic review of 119 trials (n=55,641 participants) evaluating implementation strategies
for improving BP control demonstrated that multi-level team-based care with non-physician health worker
titration of BP lowering medicines was the most effective approach for lowering systolic BP (-7.1 mmHg [95%
CI: -8.9, -5.2], 10 trials).3 The most effective patient-centered interventions for lowering systolic BP were health
coaching (-3.9 mmHg [95% CI: -5.4, -2.3], 38 trials) and home BP monitoring (-2.7 mmHg [95% CI: -3.6, -1.7],
26 trials). Importantly, <20% of the studies in this systematic review were from low- and middle-income
countries, and none were from sub-Saharan Africa.
Translating these findings into routine clinical practice requires systems to track patients, performance
review, algorithms, physicians to cede control to non-physicians, and non-physicians to cede control to and to
support patients, much like how HIV care is structured throughout sub-Saharan Africa. Our pilot data (n=60)
from Abuja, Nigeria already demonstrate feasibility and short-term efficacy in lowering systolic BP at 1 month
with community health worker-led care (-10.5 mmHg [95% CI: -15.4, -5.5]) and home BP monitoring (-7.3
mmHg [95% CI: -11.7, -2.8]) compared with usual care.
In this proposal, we will utilize implementation science methodologies including the Reach Effectiveness
Adoption Implementation Maintenance (RE-AIM) framework to adapt, implement, and evaluate an evidence-
based, multi-level intervention that includes: (1) system-level hypertension program adapted from Kaiser
Permanente Northern California's model in public, primary health care facilities in Federal Capital Territory
[Abuja], Nigeria, and (2) patient-level health coaching with home BP monitoring in a sample of high-risk
patients with uncontrolled hypertension. We will study the effectiveness and implementation of these adapted
interventions through an interrupted time series design on hypertension treatment and control rates, as well as
patient-centered outcomes. We
as
will also evaluate the implementation outcomes using the RE-AIM framework,
well as acceptability and cost, at system and patient levels for both interventions.This proposal directly addresses critical challenge #11 of the NHLBI's Strategic Vision: “Multidisciplinary,
multinational partnerships are needed to develop effective and sustainable strategies for combating chronic
HLBS disorders in developing nations, which take into account the highly variable local epidemiology of HLBS
disorders, the need for novel approaches to reducing disease burden, and the challenges of implementation.”4

Public health relevance
PUBLIC HEALTH RELEVANCE Nearly and half o Nigerian adults have hypertension, yet awareness, treatment, and control rates are very low reflect major opportunities for improving the quality of care. f Using a type 2 hybrid study design and the RE-AIM framework, we will adapt, implement, and evaluate the effectiveness and implementation of an evidence-based multi-level intervention in primary health care facilities in Nigeria's capital of Abuja of a system- level hypertension program and additional impact of patient-level and patient-centered health coaching and home blood pressure monitoring led by community health workers. Given the tremendous individual and societal cost of untreated hypertension within low- and middle-income countries, the proposed study is of global public health import.